Symposium on Population Health Informatics

DESCRIPTION (provided by applicant): Our objective is to host an in-person meeting on March 27th, 2014 to develop a national research and development roadmap for the new field of Population Health Informatics. The Center for Population Health IT (CPHIT) at Johns Hopkins Bloomberg School of Public Health will host this event with an aim towards bringing together national experts and leading researchers from academia, the public sector, provider organizations, and the IT Industry. This symposium aims to convene a participator, interactive symposium to help set national research priorities and a research roadmap for this new field of population health informatics.

Public health relevance
Public Health Relevance Statement: As an emerging field Population Health Informatics (PopHI) needs research agenda-setting. This is particularly critical given the profound transformation of the health care and HIT fields taking place at this time due to the Affordable Care Act (ACA), and the Health Information Technology for Economic and Clinical Health (HITECH) initiative, as well as widespread reforms by private and public payers moving towards population based accountable care organizations (ACO) and patient centered medical homes (PCMH) which embody population health principles. This participator, interactive symposium will be a first of its kind bringing together researchers, technical and policy experts, and thought leaders from academia, government, and industry to help set research and development priorities for the field. __SpecificAimsTextDelimiter__ Specific Aims Our objective is to host a one day in-person symposium on March 27, 2014 to help develop a national research and development roadmap for new field of "population health informatics". The Center for Population Health IT (CPHIT) at Johns Hopkins Bloomberg School of Public Health will host this event in downtown Baltimore. Attendees will include national experts and leading researchers from academia, the public sector, provider organizations and the IT industry. Population health informatics (PopHI), which is also commonly termed "population health IT", is an emerging field that creates bridges between public health informatics, clinical care and the health care delivery with the target of improving healthcare system effectiveness and wellbeing of communities and other target populations. The aim of this symposium is to convene a participator, interactive symposium for approximately 75-100 leaders in academia, health care, government, and industry to help set national research priorities and a research roadmap for this new field of population health informatics. The key objectives are: 1. Develop a consensus definition of population health informatics 2. Identify the key priorities of the field in terms of opportunities of using HIT to impact the health of populations 3. Identify key challenges and technical hurdles facing the field 4. Suggest an agenda/roadmap for research in this field over the next 5-10 years 5. Identify enabling recommendations to facilitate this agenda that could be implemented by key stakeholders including researchers, policymakers, HIT users, and R&D funders located within government and private sector 6. Develop conference proceedings to nationally disseminate the conference findings to the relevant stakeholders with interest in the PopHI field.